Investigating CNR1+ Corticostriatal Activity in Co-Exposure Models of FASD

PROJECT SUMMARY
Fetal Alcohol Spectrum Disorders (FASDs) are the most common neurodevelopmental disorders
worldwide. Numerous studies have documented the causal role of gestational alcohol exposure in
offspring anatomical and neurobehavioral FASD phenotypes. However, in human populations, FASD
outcomes are frequently complicated by additional co-occurring but poorly understood risk factors,
including paternal preconception alcohol consumption and maternal co-use of other psychoactive
substances (polysubstance use). Recent studies indicate that both of these co-occurring variables can
increase the risk of FASD symptoms in offspring. Therefore, the objective of this proposal is to
investigate, in rodent models, translationally relevant forms of PAE, i.e., 1) paternal preconception
alcohol use, and 2) maternal co-use of alcohol with a common psychoactive drug class, cannabinoids.
My central hypothesis is that these two variables will exacerbate behavioral deficits and interfere with
cannabinoid receptor 1 (CNR1)-regulated corticostriatal activity, a neural circuit associated with FASD-
characteristic behavioral disorders. The K99 phase will include investigations of dual-parental alcohol
exposure. Specific Aim 1 will test my hypothesis that dual-parent alcohol exposure impairs affect and
increases alcohol-seeking behaviors in adult offspring compared to single-parent exposures. Specific
Aim 2 will use ribosome labeling/capture to investigate transcriptomic changes in corticostriatal
synapses in adult offspring, and test my hypothesis that offspring with dual-parental alcohol exposure
will exhibit greater reductions in synaptic CNR1 transcript networks than single-parent exposures. The
R00 phase extends from my research findings that offspring with prenatal simultaneous alcohol and
cannabinoid exposure (SAC) consume more alcohol than single-drug exposed offspring. In Specific
Aim 3, I will perform in vivo and ex vivo assessments of corticostriatal CNR1+ activity using circuit-
specific chemogenetic interventions. I will synthesize behavioral, genetic, and physiological measures
to test my hypothesis that SAC-associated motor impairments and ethanol self-administration are
attributable to hyperactive glutamate transmission from CNR1+ corticostriatal neurons.
This project will advance our understanding of the impact of common risk factors on PAE-induced
neurodevelopmental outcomes, improve strategies to mitigate PAE-associated risks, and provide
foundational support for my future transition to an independent investigator. This research addresses
specific priorities listed in NIAAA’s latest Strategic Plan by 1) investigating paternal alcohol exposure
contributions, and 2) identifying neurobiological mechanisms underlying health consequences that
persist into adulthood. Finally, this work will enhance the translational relevance of animal models to
human FASD, and inform public health recommendations surrounding gestational substance exposure.

Public health relevance
PROJECT NARRATIVE Gestational alcohol exposure is a well-established causal factor in Fetal Alcohol Spectrum Disorders (FASD). However, in human populations, similar maternal exposures may result in variable FASD outcomes, suggesting that other risk factors may contribute to the severity of FASD. This project will investigate the contributions of two poorly understood but common risk factors: paternal alcohol consumption in the preconception period and maternal polysubstance use, which will enhance the translational relevance of animal models to human FASD and inform public health recommendations surrounding gestational substance exposure.